timsTOF fleX MALDI-2 for Spatial Molecular Imaging

PROJECT SUMMARY/ABSTRACT
This shared instrumentation proposal seeks funding for the purchase of a Bruker ‘timsTOF fleX MALDI-2 for
Spatial Molecular Imaging’ including a bundled HTX M3+ sprayer. This new mass spectrometry (MS) platform
will facilitate ongoing and future scientific research to spatially resolve molecular signatures, even in a multi-omic
workflow monitoring proteins, glycans, lipids, and metabolites all within the same tissue down to a spatial
resolution of ~5-10 µM. All costs will be accounted for with this proposal. We propose to operate this integrated
timsTOF fleX MALDI-2 mass spectrometry system exclusively for spatially resolved molecular imaging of human
and animal tissues and organoids as part of large group of 18 independent principal investigators from the Buck
Institute and seven other institutions or universities. These researchers bring together 19 NIH-funded grants
(including P01, U54, U01, R01, P30, UG3 activity codes) and one R01 supplement, all of which have significant
needs for state-of-the-art mass spectrometry for spatially resolved proteomics, metabolomics, lipidomics and
glycan analysis – even in a multi-omic systems approach. The most critical features of this new instrumentation
will be the 1) second post-ionization laser (MALDI-2) to greatly reduce noise and to improve ionization and
sensitivity substantially, 2) full MS Imaging workflow solutions with workflows using the HTX M3+ Sprayer Bundle
for sample preparation and matrix application required for MS Imaging, 3) high spatial resolution to reveal small
distinct architectural features in tissues, 4) dual TIMS ion mobility for reduction of complexity, separation of
isobaric features and increased sensitivity and selectivity for improved MS Imaging, 5) lipid and metabolite MS
Imaging using ion mobility cross section (CCS) measurements as additional identifier (CCS) using the
MetaboScape Databases and SCiLS (combination of m/z and CCS in spectral libraries and databases), and 6)
true multi-omic approach for MS Imaging. Overall, the acquisition of this instrument to the Mass Spectrometry
Core at the Buck Institute for Research on Aging will provide unique and novel features that will bring innovation
and totally novel capabilities (spatial molecular MS Imaging) for our 18 proposed user projects that are
examining key issues of human health and health span, including the this innovative mass spectrometry
molecular imaging technology to study the biology of aging including differential aging of specific organs and to
investigate age-related diseases, including Alzheimer’s and Huntington’s disease, a Parkinsonism, osteoarthritis,
kidney diseases and metabolic disorders.

Public health relevance
PROJECT NARRATIVE This new instrumentation will significantly improve the ongoing research of 18 independent investigators at seven different academic institutions who will use this innovative mass spectrometry molecular imaging technology to study the biology of aging including differential aging of specific organs and to investigate age-related diseases, including Alzheimer’s and Huntington’s disease, a Parkinsonism, osteoarthritis, kidney diseases and metabolic disorders. In addition, aging processes are widely understudied, and any deeper mechanistic insights or therapeutic interventions will have highly relevant impact on human health span and the society in general.